Reducing HIV-related Intersectional Stigma and Risk among People who Inject Drugs in a High Risk International Setting

PROJECT SUMMARY/ABSTRACT
Stigma is a pervasive barrier to preventing HIV among persons who inject drugs (PWID). Kyrgyzstan is part of
the world’s most rapidly expanding HIV epidemic in the Eastern Europe and Central Asia (EECA) region, where
HIV is predominantly concentrated among PWID. Our previous work with PWID in Kyrgyzstan found experiences
of HIV, drug use, and drug treatment (i.e. methadone) stigmas were associated with greater HIV risk behavior
and low use of evidence-based HIV services, including syringe service programs (SSP) and methadone to treat
opioid use disorder (MMT), which limited, timely HIV diagnoses. Following the launch of pre-exposure
prophylaxis (PrEP) services in Kyrgyzstan, PrEP awareness increased among PWID with limited uptake but was
not associated with stigma suggesting integrating PrEP referrals in stigma reduction programming may increase
PWIDs engagement in PrEP and other evidence-based HIV services. Yet there is little to no evidence base on
the potential effectiveness and implementation needs of evidence-based stigma reduction strategies that
address HIV-related intersectional stigma at multiple levels with PWID in the EECA region.
In line with NIDA and OAR priorities, the long-term goal is to rapidly advance evidence-based stigma mitigation
efforts among PWID to improve HIV service uptake and turn the tide on the rapidly expanding EECA HIV
epidemic. To achieve this goal, the current study will use the ADAPT-ITT model to adapt and refine effective
community-level and health facility-level HIV stigma reduction strategies to intervene on intersecting drug use,
MMT, and HIV stigma in the local context among PWID and MMT clinic staff (AIM 1). We will pilot the resulting
multilevel stigma reduction intervention – LIFT – using a randomized waitlist control trial study design to evaluate
the preliminary effectiveness of the LIFT intervention on stigma reduction and MMT/PrEP use (AIM 2) among 68
PWID and all staff from two MMT clinics. In parallel, a sequential mixed methods design will evaluate LIFT
implementation outcomes and needs among our local implementation partners and 25 key stakeholders (AIM 3)
to develop implementation strategies that can accelerate the pace and scale up of EECA stigma reduction efforts.
To reduce risk of contamination via injection and treatment networks, we will conduct all community- and health
facility-level intervention and waitlist control activities in distinct geographic districts in the capital city of Bishkek.
This R34 pilot is the first EECA study to evaluate intersectional stigma mitigation efforts among PWID to reduce
HIV transmission risk. This R34 is significant because stigma remains a fundamental driver of HIV transmission
globally. This R34 pilot is highly innovative because it extends the current state of HIV stigma intervention
research by integrating strategies that target intersecting stigmas at multiple levels to improve the impact of
evidence-based HIV services and advance the use of implementation science models, methods, and measures
to accelerate our understanding of how to close the stigma reduction research to practice gap.

Public health relevance
PROJECT NARRATIVE Kyrgyzstan is part of the world’s most rapidly expanding HIV epidemic in the Eastern Europe and Central Asia region, where HIV is predominantly concentrated among persons who inject drugs (PWID). Our previous work documented that while awareness of PrEP is increasing among PWID, uptake is low, and intersecting stigmas related to HIV, drug use, and drug treatment (i.e. methadone) uniquely amplify HIV risk in this population and impede the use of evidence-based HIV services such as HIV testing, syringe service programs, methadone maintenance therapy. Evidence speaking to the potential for multilevel stigma reduction strategies to unlock the prevention power of these services for PWID in Kyrgyzstan and the broader EECA region is needed.